Economic Evaluation and Research Prioritization of Adult Hearing Screening in the US

PROJECT SUMMARY/ABSTRACT
Hearing loss affects over 70% of US adults at some point in their lifetime and has significant effects on
patient quality of life and overall health. Effective treatment for mild to moderate hearing loss includes hearing
aid provision, but over 80% of adults with hearing loss do not use a hearing aid. One factor contributing to this
treatment gap is lack of awareness of hearing loss and no uniform guidance around hearing screening in
adults. Current guidelines on US adult hearing screening are conflicting, and overall rates of screening in the
US are low despite the potential for early detection and linkage to beneficial care.
This lack of uniform guidelines is in part due to the absence of sufficient quantitative evidence on the long-
term clinical and economic effects of adult hearing screening strategies in the US. The proposed research
seeks to address this evidence gap and has the long-term goal of helping US clinical and policy
decisionmakers identify the most effective and cost-effective adult hearing screening programs for their
populations. Aim 1 develops and validates a decision modeling framework of adult hearing screening,
diagnosis, and treatment in the US. These modeling efforts are in conjunction with an ongoing Lancet
Commission on Hearing Loss that will provide clinical and policy expert guidance and support. Aim 2 will utilize
the modeling framework from Aim 1 to project clinical and economic effects of alternative adult hearing
screening programs in the US. The analysis will project costs and benefits of screening interventions that vary
by age at first screen, screening frequency, and screening test modality. Aim 3 will estimate the economic
benefit obtained from reductions in uncertainty of model inputs that can be achieved through future research.
This Aim will inform future adult hearing screening research prioritization through value of information analysis.
The results of these three Aims will clarify optimal policy and investment in research targeting adult hearing
screening in the US.
This fellowship application is designed to prepare the PI to achieve his long-term goal of becoming an
independent physician scientist using decision science to increase the value and provision of care for aging
populations. Towards that long-term goal he will develop skills in advanced methods in decision science and
population health sciences, maximize the policy relevance of his research, gain further clinical experiences and
integrate clinical knowledge into his research, and build professional skills key to a successful career. The
rigorous clinical and research training proposed will enable the PI to be well-positioned for his future career as
a clinician investigator.

Public health relevance
PROJECT NARRATIVE One third of adults over the age of 60 in the United States have some degree of hearing loss, yet the majority do not receive beneficial treatment often due to lack of awareness of their hearing loss. Current guidelines around adult hearing screening are conflicting and there is a dearth of evidence around the long- term potential clinical and economic outcomes of alternative adult hearing screening strategies in the US. The proposed research will create a decision modeling framework to evaluate adult hearing screening strategies in the US and identify opportunities for future research investment with the long-term goal of helping decisionmakers select the most effective and cost-effective adult hearing screening strategies for their population.